Clinical Protocol and Data Management

ABSTRACT
A critical component of the mission of the University of Chicago Medicine Comprehensive Cancer Center
(UCCCC) is to offer patients the best and most personalized treatments available. The overall goal of the
Clinical Protocol and Data Management (CDPM) is to establish and maintain the resources and processes to
centralize and integrate the multidisciplinary component, and multidepartmental activities required to run and
oversee a broad portfolio of clinical trials, including national cooperative group trials, other NCI/CTEP-
sponsored trials and investigator-initiated trials developed through members’ translational research. An
overarching theme is to ensure adequate enrollment of women, minorities, and children on our studies. The
backbone of these operations is the Cancer Clinical Trials Office (CCTO), which is responsible for a) regulatory
management for all adult cancer clinical trials, b) protocol tracking and management through a centralized
Clinical Trials Management System (Velos eResearch); c) affiliate institution coordination and oversight,
including 7 National Clinical Trials Network (NCTN) and Personalized Cancer Care Consortium affiliate
networks, as well as over 40 additional ad hoc institutions; and d) quality control through centralized education
and training, and formalized data and safety monitoring. We have well-established guidelines and a training
manual for orientation of new regulatory managers as well as a centralized website with training videos,
reference materials and Standard Operating Procedures (SOPs). The Office interacts closely with the UCCCC
Information Technology Group, the Protocol Review and Monitoring System and the IRB. In 2016, the CCTO
opened 152 new protocols (24% were investigator-initiated); a total of 914 patients were enrolled on
therapeutic trials with 19% being minority (13% African American) and 48% women; 3286 patients were on
non-interventional trials, with 49% minority (46% African American) and 56% women. Over the current grant
cycle, we have streamlined and strengthened our audit program and instituted a number of efforts to increase
accrual to trials including: e-newsblast to referring physicians, reformatting public-facing clinical trials listing on
the UCCCC website, and development of new education and training materials, as well as building clinical
trials infrastructure in our growing off-site network affiliates. Over the next five years, we plan to continue on
this trajectory of improved and more efficient service, as well as to develop new services as needed. Major
University of Chicago Medicine strategic initiatives, such as the additions to our integrated to network, as well
as our network of off-site locations will necessitate continued expansion and refinement of our clinical research
infrastructure including: a) Expansion of clinical trial access and functionality at network sites; b) Continued
development and implementation of strategies to increase patient accrual; and c) Building on existing
integration with Departmental research staff (e.g., data managers and nurses) through training and joint SOPs.